Integration of Mental Health Services in HIV Care for Adolescents and Youth in Kenya

Project Summary/Abstract
Common mental disorders like depression, anxiety and trauma disproportionately affect adolescents and youth
with HIV (AYH), and are associated with antiretroviral treatment (ART) non-adherence and poor viral
suppression. The integration of mental health services in HIV care for AYH is recommended. However, there
are gaps in integrated mental health assessments, care and referral to mental health specialists. Non-specialist
providers form the bulk of providers in HIV clinics. In previous studies, they reported limited competence to
comprehensively assess and manage mental disorders, heavy workloads and few mental health specialists in
the clinics. There is an urgent need for implementation strategies to support consistent assessments, treatment
and an effective interface between the HIV clinic and mental health specialists. Regarding treatment for mental
disorders within the HIV clinic, adaptation and evaluation of the treatments is required considering the unique
HIV care context before implementation work is relevant. In this project, we propose to develop, pilot and cost
implementation strategies for integrating assessments and effective referrals for common mental conditions
among AYH ages 15-24 years. Aim 1 will identify barriers and facilitators for integrated assessments and
successful referral of AYH in need to specialists. We will conduct focus group discussions with providers and
AYH, and in-depth interviews with mental health specialists, HIV program and policy leaders in Kenya. Aim 2
will identify strategies that address barriers to the implementation of assessments for common mental
disorders, and successful referral for those in need to specialists. We will hold two stakeholder workshops with
providers, mental health specialists, program leaders, AYHIV and their caregivers. They will validate barriers
and conduct barrier prioritization using novel methods that allow stakeholder collaboration in assessing barrier
criticality, ubiquity, frequency and equity. Using implementation roadmaps, we will match strategies to
prioritized barriers, specifying the causal chain from implementation strategy to implementation outcomes. Aim
3 will determine whether the strategies identified improve implementation of assessments and successful
referral to specialists for those in need. We will pilot two top-rated implementation strategies in 6 HIV clinics,
and assess their effect on reach of the assessments and successful referral of AYH using an interrupted series
design, fidelity of assessments and acceptability of the strategies. Further, we will conduct a time-driven,
activity-based micro-costing analysis to inform the scale-up of the implementation strategy by the HIV program,
and assess contextual determinants of implementation with providers and AYHIV. This research matches with
Dr. Mugo’s training goals to build competence in advanced implementation science methods, qualitative and
mixed methods, stakeholder engagement methods and economic evaluation, and skills in scientific leadership
in order to transition to an independent research career that advances high quality mental health care for AYH.

Public health relevance
Narrative This research aims to inform integration of mental health care within routine HIV services for adolescents and youth in Kenya. We will develop, pilot and cost implementation strategies for integrating assessments for common mental disorders among adolescents and youth with HIV ages 15 to 24 years, and effective referrals to specialists. Dr. Mugo seeks to build expertise in advanced implementation science methods, qualitative and mixed methods, stakeholder engagement, and skills in scientific leadership in order to transition to an independent research career that advances high quality mental health care for adolescents and youth with HIV.